MODULATION IN ESSENTIAL HYPERTENSION--THE AT1 RECEPTOR

Effect of acute and chronic angiotensin (AT1) receptor blockade on the aldosterone and renal blood low responses to acute angiotensin II infusion in humans (normal subjects, modulators and non-modulators).